Impacts of Organizational Variations on Access Management

Background: Delays in care (i.e., poor access to timely care) are associated with adverse impacts on
morbidity, mortality and quality of life, as well as poor outcomes from physical and mental health conditions.
The VHA healthcare system has long struggled with access issues, however, VHA's “access crisis” in 2014,
where systemic access problems were identified after whistleblowers revealed intentional cover-ups of long
delays, drew particular outrage as evidence emerged that Veterans had died waiting to see their VHA doctors.
Improving Veterans' access to care continues to be among VHA's top priorities, and while expansion of access
to community providers has been among the most visible approaches to reducing waits and delays, VHA has
implemented numerous initiatives to improve Veterans' timely access to care within VHA as well. These
include development of a group practice manager role to facilitate face-to-face and virtual appointment-making
through call centers and access management tools (e.g., grid validation). Improving access management—
effectively deploying clinic personnel, resources, and processes to achieve timely access—remains a major
challenge nonetheless, especially across widely varying organizational and geographic contexts. Despite their
importance, remarkably little is known about which of these strategies have been implemented, the factors that
support or hinder their use, or their relationship to access metrics.
Specific Aims: To address these gaps, we propose the following specific aims:
Aim 1: To assess national variations in how local VA facilities manage primary care access.
Aim 2: To evaluate how different access management strategies relate to access metrics.
Aim 3: Building on results from Aims 1 and 2, to conduct a national expert panel to come to consensus on
evidence-based practice and policy recommendations to improve access to care.
Methods: For Aim 1, we propose to use key informant-based organizational surveys to assess implementation
of access management strategies on a national basis. We will examine area and organizational determinants
of their uptake, use and implementation by linking resulting survey data with Area Resource File measures
(e.g., urban/rural, primary care shortage area), facility characteristics (e.g., complexity, academic affiliation),
and other organizational measures (e.g., PACT Implementation Index). For Aim 2, we will then link data from
Aim 1 to VHA access metrics, including both administrative (e.g., appointment wait times) and patient-reported
access measures (e.g., obtained care when needed). For Aim 3, we will use modified Delphi panel techniques
to bring together VA and non-VA experts in access management, primary care, care coordination and other
areas to generate evidence-based recommendations based on data from Aims 1 and 2.
Anticipated Impacts on Veterans' Healthcare: The proposed study will provide critical information for VA
leadership to better understand which access management strategies have been implemented, what has
driven uptake and implementation, the barriers and facilitators to their use, and which of them are in fact
associated with better performance on access metrics. No other data sources are available to lay the
groundwork for evidence-based approaches to solving VHA's access crisis on this scale despite the resources
being applied. This study will yield multilevel targets for intervention and implementation in partnership with
senior leaders and other stakeholders.
Next Steps: We will work with leaders in Primary Care and Office of Veterans' Access to Care to disseminate
findings to the field. During the Expert Panel, we will confer with panelists to identify optimal means of
communication, including but not limited to issues briefs, toolkits, field guides, workgroups or other methods.

Public health relevance
Delays and waits for needed health care result not only in lower patient satisfaction but adverse impacts on patient outcomes. While VHA has long struggled with access problems as a result of influxes of Veterans after wartime or in response to needs of new (e.g., traumatic brain injury) or aging cohorts (e.g., long term care), VHA's highly publicized access crisis in 2014 drew demands for immediate action. That action has taken the form of expansion of Veterans' access to community providers and policy and practice action within the VA. Improving how VHA manages access through more effective deployment of clinic personnel, resources, and processes to achieve timely access is a top priority. Oddly, the evidence base on effective access management strategies remains scant, requiring new approaches to accelerating how research can support VHA access improvement efforts. The proposed study aims to provide a national profile of how VHA has responded to the access crisis, and explore what drives or hinders successful efforts to improve access.